Pathology Network Shared Resource

The Pathology Network Shared Resource (PNSR) provides human specimens and laboratory services for
basic and translational research to further the understanding of the pathogenesis of human cancers and
facilitate discovery of biomarkers for new precision medicine approaches. The overall mission of the PNSR is
to facilitate collection and access to bio-specimens for research conducted at Roswell Park Comprehensive
Cancer Center. The PNSR provides five key service areas: Procurement, Pathology Core Services, Correlative
Science Pathology Office, Bio-specimen Bank, and Image Analysis. In the reporting period (2013-2017), the
PNSR served a total of 202 Roswell users, of which 131 (88%) were CCSG members. The Specific Aims of
the PNSR are: 1) To consent, collect, and store high quality tumor bio specimens. The PNSR oversees the
consenting and collection of tumor specimens under a highly standardized process with IRB approval. This
includes both routine surgical collections as well as specialized collections of metastatic disease, fresh tissue,
or longitudinal collections in accordance with specific clinical protocols; 2) To provide state-of-the-art tissue
analyses platforms. The PNSR provides a robust suite of tissue analysis tools to enable the comprehensive
analysis of tissues. Standard histology and immunohistochemistry services are complemented by laser
capture microdissection and spectral karyotyping; 3) To provide expertise for study design, grant preparation,
and clinical trials. Staff within the PNSR plays an active role in designing biomarker studies and rigorous
methods for evaluating data that emerges from the analysis of tissues. These integrated features of the PNSR
provide an important platform for grant submissions and facilitate development of correlative studies in the
context of clinical trials. There are limited options for bio specimen acquisition with the level of quality and
annotation that is provided by the PNSR. Acquiring fresh or frozen tissue from external tissue banks is costly,
requires considerable legal work (e.g. MTAs), and reliability can be questionable, our costs for these activities
in comparison to external sites provide more affordable service for CCSG members. Furthermore, the
convenience of these resources is an added benefit to investigators in terms of saving them time and ease of
discussion related to design and interpretation of data. Services within the PNSR are accessible to any
researcher that has appropriate IRB approval for the proposed work. The PNSR plans to be at the forefront in
all areas of operation to facilitate cutting-edge research that will lead to significant changes in the prevention
and treatment of cancer. Specialized procurement is critical for this goal given the importance of
understanding metastatic, recurrent, and therapy resistant disease.